P20 Exploratory Center for Precision Health in Diverse Populations

Abstract/Project Summary
The primary objective of the NYU Meyers P20 Exploratory Center for Precision Health in Diverse Populations
Pilot Administrative Core (PAC) is to develop and maintain an innovative program to support early stage
investigators in conducting pilot research and generating preliminary findings to address biologically diverse
and common mechanisms, symptoms, modifiable and non-modifiable factors that underlie MCC. The PAC will
work synergistically with the Administration Core, Precision Health Technology Core and Enrichment Program;
and leverage the considerable resources of NYU to support pilot projects funded by the Center. This synergy is
essential to maximize rigor and impact of proposed research in the Center's central theme and ensure
development of innovative nursing research and interdisciplinary collaboration in MetS and related MCC. The
specific aims of the PAC are: Aim 1: To facilitate, select, plan and oversee all aspects of pilot projects. Projects
will use a precision health ecological perspective and CDEs to conduct innovative research on MetS, MCC,
and the complexity, relatedness, biodiversity, and impact of MetS and MCC on individuals and families;
Aim 2. To provide continuous, individualized mentorship and strong academic and technical support to
awardees to maximize rigor, innovation, and impact of proposed studies, promote interdisciplinary
collaboration, and enhance awardees' capacity to compete for federal funding to build their independent
research careers in the center's theme; Aim 3: To promote development of innovative, high-impact research
products (e.g., manuscripts, proposals, conference presentations); and Aim 4: To organize and monitor
common measurement and analytic strategies to support CDE utilization that contributes to a MetS/MCC
database. Through management of all aspects of the pilot projects (from selection of projects through
dissemination of research findings) in close partnership with the pilot PIs, the PAC will foster independent
research careers of the funded investigators. As a result, the PAC will help coalesce a network of innovative
nurse scientists and interdisciplinary collaborators dedicated to building the science of MCC from a precision
health ecological perspective through impactful research that accelerates nursing science. Through the
consistent use of CDEs across the pilot projects, the PAC will build a MetS/MCC database to support ongoing
and future research. In this way, the PAC supports the NINR's strategic plan in symptom science through
projects that illuminate omic, biobehavioral, lifestyle and environmental explanations that inform nursing care
for patients who present with symptoms of MetS by allowing for more individualized care.